Olfactory receptor-based sensors for biomedical applications

Project Summary/Abstract
Olfactory receptors (ORs) are one of the largest family of chemical detecting cell-surface receptors in
humans. ORs are expressed beyond the olfactory tissue, with 55 ORs highly expressed ectopically (exORs) in
18 different tissues, where they drive tissue-specific processes including sperm chemotaxis and muscle
regeneration. The majority of exORs, however, have no known ligands; they are orphans, which limits the ability
to understand their role in human health, including 1) elucidation of exOR downstream pathways in the
endogenous tissue, 2) the identification of exOR endogenous ligands, and ultimately 3) an assessment of exORs
as potential therapeutic targets. During the MIRA renewal period, the goal is to leverage the OR-based sensor
technology to generate large sets of high-quality experimental exOR-ligand data to train machine learning
models to predict ligands for the 36 currently orphaned exORs. Such an algorithm would vastly accelerate exOR
deorphanization, and may prove to be general, enabling the deorphanization of all 302 orphan ORs. The long-
term goal is to use the identified ligands that activate the exORs to tease out their role in human health, including
identifying the endogenous exOR ligands in the tissues in which they are overexpressed, and determining the
downstream processes in which they are involved. This understanding will enable an assessment of exORs as
therapeutic targets, and open the door to new, first-in-class therapeutics.
Olfactory receptors belong to the class of cell surface proteins called G-protein coupled receptors (GPCRs).
Non-sensory GPCRs are involved in a myriad of biological process, from cell migration to immunity, making them
important therapeutic targets. GPCRs signal combinatorially, with ~100s of GPCRs expressed in mammalian
cells signaling via a total of 17 G-protein subtypes—resulting in extensive crosstalk between GPCR signaling
pathways, often with important therapeutic implications. A gap in knowledge exists in understanding the extent
of GPCR signaling pathway crosstalk and its effect on cellular processes and animal behavior. Dissecting GPCR
signaling pathway crosstalk will enable 1) the identification of GPCR signaling pathways leading to
therapeutically desired outcomes, vis a vis pathways leading to side effects, towards the development of more
precise and safer therapeutics, and 2) a more nuanced understanding of GPCR signaling that will be crucial for
the engineering of next-generation therapeutic cells. During the MIRA renewal period the goal is to develop a
chemogenetic toolset to combinatorially activate/deactivate multiple (≥ 3) GPCR signaling pathways while
leaving the rest of the cell intact in order to fully dissect the effects of GPCR signaling crosstalk and its biomedical
implications. The long-term goal is to ultimately enable combinatorial control of up to 17 different GPCR signaling
pathways, providing access to cellular phenotypes that may explain how combinatorial GPCR activation can be
leveraged for the development of new therapies and the GPCR-based circuit architecture could inspire the
development of next-generation sense and response therapeutic cells.

Public health relevance
Project Narrative The goal of the proposed research is to elucidate the role olfactory receptors (ORs) expressed outside the olfactory tissue play in human health and asses their potential as therapeutic targets. Olfactory receptors are a subtype of transmembrane proteins called G-protein coupled receptors (GPCRs), which are an important therapeutic target. As part of the proposed research, we also work towards understanding how GPCR signaling pathways talk to one another and the consequences of this crosstalk to human health, with the goal of enabling the development of new therapies.